A machine learning approach to increasing diagnostic accuracy in Atypical Alzheimer's disease cases with clinical-radiological mismatch

Project Summary Machine-learning (ML) approaches have been applied for automatic diagnosis and prognosis of Alzheimer's Dementia (AD) using Magnetic Resonance Imaging (MRI). These studies use highly variable training and testing datasets and consequently confound objective comparison of classification between methodologies because of differences between datasets, feature extraction, feature selection, and validation methods. The hypothesis of this proposed project is that advanced ML co-analysis of commonly used MRI imaging and neuropsychological information may hold potential for improved hard-to-detect AD diagnosis. This study proposes a fully automated two-step AD diagnosis framework for patients with dementia through the following Specific Aims: Aim 1: To discover volumetric MRI imaging biomarkers for dementia by studying feature-based multiresolution-fractal texture extraction, Kullback-Leibler Divergence (KLD) multiclass feature selection, and fusion with feature-less deep ML methods. In this Aim, we will design hand-crafted MRI features and featureless deep learning methods to obtain imaging features. Multi-class KLD will be developed to select and fuse different features to generate MRI biomarkers. Aim 2: To combine advanced regression based feature fusion and prediction for MRI biomarkers and neuropsychological information informant history, AD risk factors, and functional status for accurate and hard-to-detect AD classification. This Aim systematically fuses the newly discovered MRI imaging biomarkers with a battery of non-imaging features to target the atypical AD cases where volumetry and neuropsychological testing alone may not yield AD detection. This will help to reduce the number of patients that will need referral for further more expensive PET imaging for diagnosis of AD.

Public health relevance
Project Narrative There is need to understand the effect of combining feature-guided deep Magnetic Resonance Imaging with other data, such as neurophysiological data, informant history, Alzheimer's dementia risk factors, and functional status, for accurate diagnosis of atypical Alzheimer's Dementia cases. Early intervention has the potential to improve the quality of life of such patients. Diagnosis at the early stage may also improve patient access to support services and enable effective planning for future treatment.